Integrating Immune Dysregulation and Reward Circuitry in Veterans with Mood Disorders and Suicide"

Project Summary
Depression is among the most disabling mental health conditions and associated with profound functional
impairment resulting in tremendous economic burden for the Department of Veterans Affairs (VA). Critically,
depression is one of the leading causes of suicide, which is known to be much higher for Veterans compared
to non-Veterans. There are major gaps in knowledge regarding the fundamental pathophysiology of depression
that limit novel diagnostic and treatment approaches contributing to its health burden. Abnormal functioning in
the peripheral immune system has been linked consistently to risk for depression and suicide based on prior
empirical studies and theoretical models. Likewise, abnormalities within the brain reward system are
established risk factors for depression and suicide. However, the molecular underpinnings of peripheral
immune dysregulation – and their relationship to brain reward circuit abnormalities – is not well understood in
depression or suicide. Our prior human studies showed that circulating immune factors, such as cytokines, fail
to fully capture relevant immune dysregulation in depression, and that a clear “pro-inflammatory” profile of
elevated cytokines and chemokines was observed only following ex-vivo stimulation of peripheral blood
mononuclear cells (PBMCs) with liposaccharide (LPS). We also found that abnormally elevated peripheral
immune response was associated with lower neural response within the brain reward system, which in turn
was linked to higher levels of anhedonia and increased risk of suicide. In the proposed multi-PI study two
clinician investigators (Szeszko/Murrough) will build on our prior work by examining immune profiles derived
from LPS ex-vivo stimulation of peripheral immune cells (i.e., PBMCs) using advanced methods for proteomic
analyses. We will interrogate a brain reward circuit utilizing state-of-the-art neuroimaging methods and
integrate them with next-generation immune cell-specific proteomic approaches in 70 Veterans with major
depressive disorder (MDD), including 35 with and 35 without a prior suicide attempt history, and 60 unaffected
Veterans. Pro-inflammatory profiles derived from ex-vivo LPS stimulation of PBMCs will be examined in
relationship to in-vivo neural activity within the ventral striatum/nucleus accumbens (VS/NAc) using functional
magnetic resonance imaging during an incentive flanker task. Pro-inflammatory profiles will also be examined
in relation to in-vivo free water measures derived from neurite orientation dispersion and density imaging as an
index of inflammation within the accumbofrontal white matter tract, which connects the VS/NAc with the orbital
frontal cortex to form a reward circuit. Veterans will be followed longitudinally and receive 6-month and 1-year
assessments of suicidal behavior to determine whether baseline measures can be used to predict future
suicidal risk. We will test the following specific aims: (1) to characterize the peripheral immune profile of
Veterans with MDD; (2) to determine the relationship between peripheral immune profiles and reward circuitry
in Veterans with MDD and (3) (exploratory) to investigate the association between peripheral immune profiles,
reward circuitry, and suicidal risk in Veterans with MDD. This translational study addresses the critical need to
identify mechanisms of immune hyper-reactivity relevant for depression and suicidal risk as well as pathways
linking pro-inflammatory profiles with reward function to identify targets for treatment development. The clinical
implications of this study are underscored by the identification of pro-inflammatory profiles that could provide
novels ways of identifying Veterans who may not demonstrate adequate treatment response to traditional
pharmacotherapy due to the potential role of inflammation and advancing the utility of using blood biomarkers
to identify Veterans with depression at risk of suicide.

Public health relevance
Project Narrative Depression is among the most disabling human illnesses worldwide and one of the leading causes of suicide. Abnormalities in the immune system have been linked to risk for depression and suicide. Likewise, abnormalities within the brain reward system are established risk factors for depression and suicide. However, the molecular underpinnings of peripheral immune dysregulation - and their relationship to brain reward circuit abnormalities – is not well understood in depression or suicidal behavior. This study will address this major gap in knowledge by investigating a brain reward circuit in Veterans with major depressive disorder at risk of suicide utilizing advanced neuroimaging approaches and integrating them with next-generation immune cell- specific proteomic approaches. This study has strong clinical and translational relevance for the identification of Veterans with depression at elevated risk of suicide using blood-based biomarkers and/or those individuals who do not respond to traditional pharmacotherapy due to the potential role of inflammation.